National Association of State Head Injury Administrators State of the States in Brain Injury Conference Support

The NASHIA State of the States in Brain Injury Conference is the premier national event for brain injury professionals and those seeking to expand their expertise in this critical area. The conference will be held at the Westin Portland Harborview in Portland, Oregon from October 27-30, 2025. The conference brings together state leaders, researchers, advocacy groups, service providers, community partners, and professionals from sectors with a high prevalence of brain injury for intensive learning, networking, collaboration, and research-to-practice activities. Key objectives include fostering relationships with decision-makers and community leaders and offering content that spans the entire continuum of care with a specific focus on supporting those in the community. With advanced insights from leading experts and researchers, the conference aims to bridge research to practice, equipping participants with innovative ideas and practical tools to enhance services and improve outcomes in their own organizations.
Monday, October 27, will feature two intensive sessions focused on Long-Term Services and Supports and on Children and Youth. Tuesday, October 28 and Wednesday, October 29 will feature a General Track and two Special Tracks on the Criminal Legal System and Behavioral Health. Through the conference sessions, experts from a wide variety of sectors and people with lived experience will share best practices, knowledge, and ideas for implementation. The conference aims to disseminate research and to ensure it is applied and implemented across state practices. By focusing on evidence-based practices and innovative models of care, the conference will provide researchers, practitioners, and policymakers with the tools and knowledge to implement strategies that improve outcomes for individuals with brain injury.

Public health relevance
The National Association of State Head Injury Administrators’ annual conference advances public health by emphasizing a comprehensive, multi-faceted approach to brain injury that recognizes its complexity and broad impact on individuals and communities. The conference highlights how a variety of factors shape both the course of recovery and long-term outcomes for individuals with brain injury. Through the dissemination of cutting-edge research, including NIH-funded studies and evidence-based practices, the conference equips brain injury professionals, policymakers, and communities to implement the research among the full spectrum of brain injury’s impact, including those with chronic needs, improving access to care. Modified Budget Section Total Budget: $250,000 Portion from NINDS: $49,950 NASHIA Conference Budget Justification Total Budget: $250,000 Portion from NINDS: $49,950 NINDS Budget Items: Senior Key Personnel Salary Maria Crowley, FTE $125,000, Requesting: $15,600 Maria Crowley, Director of Professional Development, will play a key role in supporting the preparations for the State of the States Conference, dedicating a significant portion of her time to developing the conference content, managing logistics, and ensuring the smooth coordination of various activities. This will include tasks such as curating session topics, coordinating with speakers, and supporting the outreach and engagement efforts. Additionally, Maria will lead an implementation planning session at the end of the event, to support utilization of the tools and best practices that have been presented during the conference. While this allocation of time will only partially cover the full scope of responsibilities, it will be integral to the successful execution of the event. The Director’s expertise in professional development will ensure that the conference delivers high-quality content and provides a valuable experience for all attendees. Participant/Trainee Support Costs All Travel Costs (Except for Meals) for People with Brain Injury/Students/Researchers/Experts/Practitioners/Junior Investigators to Participate and Present (as appropriate): $7,000 4 Nights in Portland @ $225/night x 4 = $4,500 Flight $500 x 5 = $2,500 Registration Only for 13 Individuals $950x=13=$12,350 In addition to supporting full travel for 5 participants, to extend the reach of the conference, NASHIA has also budgeted for the registration fees of 8 additional individuals with Brain Injury/Students/Researchers/Experts/Practitioners/Junior Investigators to Participate and Present. Equipment or Facility Rental Audio Visual Costs: $15,000 The audio-visual costs for the State of the States Conference are a critical component for ensuring the event runs smoothly and professionally. These costs include the necessary equipment for live presentations, virtual speakers, breakout sessions, and the overall conference experience, including microphones, projectors, and screens. NASHIA anticipates that costs will be in line with or exceed those of previous years, and costs for last year’s conference was higher than the $15,000 requested. These costs will ensure the conference maintains its high standard of professionalism and accessibility for all participants.